Investigating sex differences in persistent valvular myofibroblast activation using hydrogel culture substrates

PROJECT SUMMARY
Aortic valve stenosis (AVS) is a progressive disease where fibroblast-like valvular interstitial cells (VICs) become
persistently activated myofibroblasts, which contribute to pathologic aortic valve leaflet stiffening. AVS is treated
with valve replacement surgeries, which may be avoided if small molecule drug combinations could be identified
to inhibit persistent myofibroblast activation. However, the molecular mechanisms regulating persistent
myofibroblast activation are unknown and may vary from patient-to-patient and/or by sex. My proposed R00
research seeks to continue characterizing the sex- and patient-specific differences that lead to persistent
myofibroblast activation during AVS and optimize drug combinations to inhibit myofibroblast activation as a
function of patient-specific cues. We hypothesize (i) sex-linked differences in how male and female VICs respond
to mechanical cues and (ii) patient-specific biochemical cues found in AVS patient sera contribute to persistent
activation and subsequent myofibroblast response to small molecule drugs. In Aim 1 (completed), we have
characterized genes that escape X-chromosome inactivation that regulate myofibroblast activation uniquely in
female VICs seeded on PEG hydrogels. In Aim 2 (in progress), we will generate persistently activated
myofibroblasts in human AVS patient sera and determine alterations (e.g. open chromatin regions) in the VIC
epigenome due to patient-specific serum factors using Assay for Transposase-Accessible Chromatin with
sequencing (ATAC-seq). In Aim 3 (proposed), we will identify optimal combinations of small molecule drugs to
inhibit persistent myofibroblast activation in the presence of AVS patient serum using a differential evolution
algorithm. In sum, the proposed research will address an urgent, unmet need for sex-specific and precision
medicine approaches for identifying molecular mechanisms of myofibroblast persistence, which may provide a
bridge toward non-surgical AVS therapies.

Public health relevance
PROJECT NARRATIVE Aortic valve stenosis (AVS) is a disease that activates aortic valve cells to stiffen valve tissue and cause heart failure. Developing drug therapies for AVS remains elusive, given that female and male patients respond differently to drugs that stop or slow valve cell activation. Our proposal seeks to understand sex differences in how valve cells activate and develop a computational platform to optimize drug combinations to inhibit activation, which may provide a path toward sex-specific treatments for AVS patients.